Expanded (Regional) Pilot and Feasibility Program

Project Summary/Abstract – Expanded (Regional) Pilot and Feasibility Program
The specific aim of the Michigan Diabetes Research Center (MDRC) expanded Regional Pilot/Feasibility Study
(P/F) Grants Program is to stimulate new research and collaboration in the areas of diabetes, its complications
and related endocrine and metabolic disorders in the region. This research may be in areas of basic
biomedical science or clinical research. This program will fund at least 2 P/F grants submitted by investigators
from our three regional partners per year. A minimum of $100,000 per year will be provided by the MDRC and
a minimum of an additional $20,000 per year will be provided through cost-sharing agreements with the
University of Toledo, Michigan State University, and Wayne State University. Each year, the MDRC will solicit
applications for grants from full-time instructional or research faculty at these three institutions. Those eligible
include: 1) new investigators without current or past NIH research support who are beginning careers in
diabetes research, 2) established investigators new to diabetes research who wish to focus their expertise on
diabetes, and 3) established investigators who propose innovative research in diabetes that represents a clear
departure from their ongoing research. Applications are peer-reviewed by at least two extramural investigators
with expertise in the area of the application. Those with merit, as judged by this review process and the Grants
Program Advisory Council, which includes representatives from the three regional partner universities, will
receive P/F awards. The ultimate goal of the grant program is to enhance communication and collaboration
among regional diabetes researchers, accelerate the pace of research, and enable awardees to generate
sufficient preliminary data for successful applications for major research funding from the NIH or other national
granting agencies.